Shared Resource Management

PROJECT SUMMARY
SHARED RESOURCE MANAGEMENT
Shared Resource Management (SRM) facilitates exceptional science by Moffitt Cancer Center (Moffitt) Members
through state-of-the-art technologies and services provided by highly trained and specialized staff. Centrally
managed Shared Resources (SRs) are developed and deployed in support of the Research Strategic Plan and
to meet the current and future needs of Members. The 14 (including 2 developing) Moffitt SRs are: Analytic
Microscopy Core, Biostatistics & Bioinformatics Shared Resource, Cell Therapies Core, Chemical Biology Core,
Collaborative Data Services Core, Flow Cytometry Core, Quantitative Imaging Core, Molecular Genomics Core,
Participant Research Interventions & Measurements Core, Proteomics & Metabolomics Core, Small Animal
Imaging Lab, Tissue Core, the developing Pharmacokinetics & Pharmacodynamics Core, and the developing
Gene Targeting Core. These SRs are maintained by 224 faculty and staff that serve the needs of Members, with
each SR supporting cancer research that ranges from basic science to population wide association studies and
interventional trials. Moffitt collectively invested over $7.9M in capital equipment for the SRs, along with more
than $7M in annual operating costs, over each of the last five years. User surveys, and scientifically-driven
planning and continual rigorous evaluation of services and resources by SR Advisory Committees of Member
needs, impact, appropriate location, project handoffs, and expectations have ensured that the SRs keep pace
with the growing needs of Members and with state-of-the-art technologies. These processes led to restructuring
or expansion of six Shared Resources, each of which rated Outstanding or better in the prior review. SRM
supports Member research through four Specific Aims:
Aim 1: Provide high-value, cost-effective Shared Resources and project workflows to Members through
centralized management, processes and policies.
Aim 2: Plan and evaluate Shared Resources to meet the Research Strategic Plan and evolving scientific needs
of the Research Programs.
Aim 3: Ensure best practices, quality, and reproducibility of research through policies, education and training.
Aim 4: Determine and ensure scientific impact and value of Shared Resources through standardized usage
tracking, evaluation of key metrics, and financial oversight.
Shared Resource Management supports SRs that serve all 5 Programs and 183 Members in aggregate (117 of
whom hold peer reviewed funding). Scientific impact is reflected in the support of $36.0M in active peer reviewed
funding and 482 peer reviewed grants, 494 clinical trials, and 883 unique publications since the last application,
including 126 publications in high impact journals (IF ³ 10). Overall centralized SRM provides state-of-the-art
resources and services to Moffitt’s research community that efficiently and effectively fosters cutting-edge
science and clinical trials.